Cross-CFDE semantic and spatial interoperability for anatomy

The potential impact of the work to be done if it were successfully implemented. This proposal looks to establish three-way collaboration between SPARC, HuBMAP and Kids First (SHKF) as a means to develop coherent anatomical knowledge/data management strategies informed by clinical use-cases. SPARC seeks to apply, in the SHKF space, SPARC-related infrastructure (e.g. SciCrunch platform [1], ApiNATOMY connectivity [2] and flatmaps, 3D dynamic organ scaffolds [3]), procedures (e.g. curational pipeline) and expertise (e.g. clinical, knowledge- and bio-engineering, neuroscientific) to foster SHKF molecular/tissue/phenotype interoperability in support of discovery, modeling and hypothesis testing, initially in the areas of the neurology of the heart and colon. In the long-term (beyond the immediate scope of this project), this effort is expected to also set the stage, and eventually facilitate, modelling and simulation (M&S) efforts in the areas of physiology-based pharmacokinetics (PBPK) and paediatric allometry (PA).